DOCUMENTATION OF PUBLIC USE FILES--1986-87 AND 1979-80 SURVEYS OF SCHOOL CHILDREN

During 1986-87 the National Survey of Oral Health in School Children was conducted by Westat Inc. in cooperation with NIDR to monitor the prevalence of oral diseases in school children, grades K-12, throughout the contiguous United States and Hawaii. The 1986-87 survey was a replication and extension of the NIDR National Dental Caries Prevalence Survey conducted in 1979-80, also by Westat, which established baseline estimates on the prevalence of dental caries, gingivitis and dental restorative treatment needs. Both surveys utilized multi-stage probability samples of over 39,000 school children enrolled in grades K- 12 to represent over 43 million children enrolled in public or private schools in the seven geographic regions of the U.S. In the 1986-87 survey, additional assessments were made for dental fluorosis, soft tissue lesions, and the use of smokeless tobacco. Residential histories, health and demographic data were collected for each child participating in the clinical examination. The objective of this continuing collaborative effort is to document the survey designs and produce public use tapes for both the 1986-87 and the 1979-80 surveys, and to provide clinical protocols and statistical methodologies for calculating national or regional estimates, weights and sampling errors. The documented tapes generated by this effort were released for public use by the National Archives.